BUDESONIDE CONTROLLED ILEAL RELEASE CAPSULES IN ACTIVE CROHN'S DISEASE

The aim of this study is to assess the efficacy and safety of budesonide compared to placebo in patients with active Crohn's disease affecting the ileum and/or the ascending colon. Approximately 200 patients nationwide will be randomized to 4.5 or 9 mg controlled ileal release capsules once or twice a day, or placebo. Budesonide is a glucocortisosteroid with high topical antiinflammatory activity and significant first-pass metablism. The primary efficacy variable will be the Crohn's Disease Activity Index remission rate.